UC San Diego Womens Reproductive Health Research Program

Project Summary
This UC San Diego Womens Reproductive Health Research (WRHR) Career Development Program addresses
the urgent need to train physician-scientists in OB/GYN and Women's Health, so that they can develop into
independent leaders who will advance Women's Health. WRHR Scholars with strong prior clinical and research
experience who are committed to academic careers as physician-scientists focused on Women's Health are
selected through nationwide searches. Led by the Recruitment Officer, the Program leadership and the Diversity
Committee select the most qualified candidates for consideration by the Internal and External Advisory
Committees. Scholars are matched with primary Mentors, who are established scientists with relevant expertise
and strong mentorship experience. The Program has a team of 23 internationally recognized Mentors, with 14
in the Department of OB/GYN & Reproductive Sciences. These Mentors, along with 24 additional Collaborators,
have diverse and complementary expertise in basic, translational, and clinical research, and conduct research
in a variety of relevant areas, including impacts of social and cultural factors on Women's Health, pre- and
perinatal physiology, family planning, female pelvic medicine, reproductive endocrinology, embryology, and
gynecologic oncology. At any given time, there are projected to be 2 WRHR Scholars, who are appointed as
Assistant Professors. The Program is organized into 2 phases: in the first 1-2 years, Scholars gain research
competency; in the subsequent 3-4 years, efforts work toward research independence and academic expertise.
In Phase 1, didactic and practical instruction in epidemiology, biostatistics, data management, and informatics
supplements intensive research training, with minimal clinical work. In Phase 2, Scholars join the UCSD National
Center for Leadership in Academic Medicine program, which teaches academic development, leadership, and
organizational effectiveness and prepares the Scholar to excel as an accomplished Associate Professor.
Individualized instruction in grant writing, ethics, and medical enterprise, and quarterly workshops on career
advancement topics, are conducted by the highly experienced Leadership Team and Program Faculty. Program
faculty closely monitor the Scholars' progress. Program leadership meet with Scholars monthly and Individual
Mentorship Committees (appointed specifically for each Scholar) meet twice per year, ensuring that the research
environment and clinical demands are optimized and balanced. The Internal and External Advisory Committees
review the Scholars annually to assess their advancement and determine reappointment to the Program. The
success of the UC San Diego WRHR Program is demonstrated by the academic achievements of its past
graduates, which in include 3 who are now members of the mentorship team. The Program looks forward to
continuing to recruiting exceptional Scholars, and providing them with the rigorous training in cutting-edge
interdisciplinary research and career development support that will enable them to succeed as independent
investigators who will make critical discoveries related to Women's Health and translate them to the clinic.

Public health relevance
Project Narrative The UC San Diego Womens Reproductive Health Research (WRHR) Career Development Program provides rigorous interdisciplinary research training and career development to prepare physician-scientists in Obstetrics and Gynecology to become leaders in Women's Health research. Exceptional junior faculty OB/GYNs with MD, MD/PhD, MD/MPH, and other dual degrees participate in a structured program that includes relevant didactic training, as well as intensive project-based training in basic, translational, or clinical research under the guidance of a well-established primary research mentor with domain expertise and an Individual Mentorship Team, with oversight by Internal and External Advisory Committees. The world-class intellectual environment at the University of California, San Diego enables the UC San Diego WRHR program to offer WRHR scholars access to a team of experienced and dedicated faculty mentors and collaborators with diverse but complementary expertise, primarily from the Departments of OB/GYN and Reproductive Sciences, Medicine, Pediatrics, Family Medicine, Pathology, and Public Health.